Project 2: Defining the role of megakaryocyte abnormalities in the progression of primary myelofibrosis

PROJECT SUMMARY
Prefibrotic myelofibrosis (PrePMF) was formalized in 2016 by the World Health Organization
(WHO) as a new early indolent form of MF which frequently progresses to myelofibrosis (MF) as
well as acute leukemia. Abnormal regulation of megakaryocyte development is a key feature of
both PrePMF and MF. Under normal conditions, committed megakaryocyte progenitors
proliferate to a limited extent and then give rise to small numbers of large, polyploid
differentiated megakaryocytes. However, upon acquisition of mutations in key signaling
molecules, such as MPL, CALR or JAK2, megakaryocyte progenitors expand and promote
thrombocytosis in PrePMF and thrombocytopenia/myelofibrosis in MF. Previous studies have
demonstrated that a deficiency of the critical megakaryocyte transcription factor GATA1 leads a
MF phenotype in mice and that levels of GATA1 are significantly reduced in the bone marrow of
MF patients. We hypothesize that the loss of GATA1 in MF leads to an aberrant gene
expression program which includes increased levels of pro-fibrotic and inflammatory cytokines
such as TGF-β, LNC2 and IL-8, and that these changes drive the transition from Pre-PMF to MF.
In our project, we will first perform a detailed assessment of cytokine secretion by PrePMF and
MF megakaryocytes from animal models and patients and determine if these alterations induce
aberrant megakaryocyte growth and fibrosis (Aim 1). Then we will assess the specific
contributions of TGF-β to the cell cycle of normal and MF hematopoietic stem cells (Aim 2).
Finally, we will use information from Aim 1 and 2, as well as from Projects 1 and 3, to study the
efficacy of drugs that target the microenvironment, malignant hematopoietic stem cells or
epigenetic regulators on MF in animal models. This work is innovative in that no one has
characterized the way that malignant megakaryocytes guide the progression from Pre-PMF, a
relative benign phase, to MF, the final fatal stage of hematopoietic failure in MPNs. Thanks to
the interactions with the other projects and cores of this PPG, we are uniquely positioned to
define the mechanisms by which megakaryocytes affect the transition from PrePMF to PMF and
the contributions of TGF-β, LCN2 and IL8 to disease. Our work is significant in that it will assist
Project 4 in prioritizing clinical trials already in the pipeline for MF and lead to new targeted
therapies for the MPNs.

Public health relevance
PROJECT NARRATIVE Prefibrotic myelofibrosis (PrePMF) is a newly appreciated early indolent form of myelofibrosis (MF) which frequently progresses to MF as well as acute leukemia. Although JAK inhibitors provide symptomatic relief, they do not significantly reduce the degree of bone marrow fibrosis and since they are not curative, are not anticipated to halt progression from PrePMF to MF. Our research will shed light on the progression of MF and also identify new targets for therapeutic intervention.